Contributions of varicella zoster virus exosomes to Alzheimer's disease pathology

Alzheimer’s disease (AD) is the leading cause of dementia for which there is no cure. Neuropathological
hallmarks include accumulation of insoluble forms of amyloid-beta into plaques located extracellularly and
within vessels, aggregation of the microtubule protein tau in intracellular neurofibrillary tangles, ischemia, and
neuroinflammation, leading to neuronal dysfunction and cognitive decline. A critical barrier in treating AD is
the years- to decades-long lag from disease onset to clinical diagnosis, when reversal of brain pathology may,
at best, slow cognitive decline. Thus, it is essential to identify early pathological processes that we can target to
slow or halt AD progression. Varicella zoster virus (VZV) is a likely contributor to AD pathogenesis because of
shared clinicohistopathological features. Like AD, VZV reactivation: 1) is a disease of older adults; 2) manifests
as cognitive impairment/dementia; 3) produces cerebral ischemia/hemorrhage and neuroinflammation; and 4)
produces intracellular amyloid and an amyloidogenic extracellular environment in vivo and in vitro. In addition,
epidemiological studies show VZV reactivation (herpes zoster) increases dementia risk and antivirals reduce
risk. In a separate line of research, exosomes are emerging as important mediators of AD pathogenesis,
potentially contributing to neuroinflammation and neurotoxicity. Given that VZV induces an amyloidogenic and
proinflammatory environment in plasma and cerebrospinal fluid of zoster and VZV vasculopathy patients,
respectively, in the absence of infectious virions, the role of virus-induced, non-infectious exosomes in creating
this environment in the central nervous system (CNS) is of great interest because it would explain, in part, why
viral nucleic acids and virions are not consistently detected in AD brains. Our preliminary data show that
compared to exosomes from mock-infected human sensory neurons (HuSNs; the cell type from which VZV
reactivates), exosomes from VZV-infected HuSNs contain a single viral protein (VZV immediate early 62), as
well as differentially-expressed cell proteins enriched for pathways associated with AD and
infectious/immunomodulatory diseases. Furthermore, we found that these exosomes can enter CNS cells and
functionally alter cellular phenotypes. Taken together, we hypothesize that VZV reactivation from HuSNs
releases pathogenic, non-infectious exosomes into the CNS, resulting in neuroinflammation and neuronal
dysfunction, overall contributing to AD pathology and accelerating progression to clinical dementia. To test this
hypothesis, we will determine if exosomes from VZV-infected HuSNs induce inflammation and alter the
transcriptome of CNS cells (Aim 1) and determine if exosomes from VZV-infected HuSNs inoculated
intranasally or intraventricularly into 5xFAD mice induce acceleration of AD pathology and neurophysiological
changes (Aim 2). Understanding how exosomes produced during VZV infection contribute to established
pathological processes in AD will provide early targets for diagnosis and treatment that may potentially slow or
even halt progression to clinical dementia.

Public health relevance
Understanding how exosomes produced during VZV infection contribute to established pathological processes in AD (e.g. neuroinflammation, neuronal dysfunction) will provide early targets for diagnosis and treatment that may potentially slow or even halt progression to clinical dementia, disability, and death.